Chemical probe discovery for PAX3-FOXO1

ABSTRACT – Project 3: Chemical probe discovery for PAX3-FOXO1
The majority of pediatric alveolar rhabdomyosarcoma (ARMS) cases are characterized by a chromosomal
translocation encoding the PAX3-FOXO1 fusion oncoprotein, a transcription factor correlated with poor patient
outcomes. The overarching goal of this FusOnc2 Center is to advance the therapeutic tractability of the PAX3-
FOXO1 fusion protein in ARMS by comprehensively identifying the druggable co-regulators, modulators, and
intrinsic activities of PAX3-FOXO1. Transcription factor fusion proteins such as PAX3-FOXO1 have been
validated through genetic approaches as key therapeutic targets, since they may represent tumor-specific
Achilles’ heels. Unfortunately, to date there are no small molecules that can modulate the function of PAX3-
FOXO1. Hence, novel approaches are needed to develop chemical probes or drugs that can target this fusion
oncoprotein. Similar to other fusion transcription factors, PAX3-FOXO1 is intrinsically disordered and lacks the
traditional small-molecule binding pockets observed in historically tractable targets, complicating structure-driven
design or small-molecule screening efforts to identify drug candidates. This Project’s objective is to develop
chemical probes for PAX3-FOXO1 using a novel emerging strategy developed within the Koehler Laboratory
against other transcription factors and recalcitrant targets. The strategy involves the use of high-throughput and
unbiased binding assays involving small-molecule microarrays (SMMs) screened with purified, full-length
transcription factor or transcription factor residing in cell lysates. We will exploit this novel technology to develop
chemical probes against PAX3-FOXO1 as the first step in drugging this protein through the following four Specific
Aims: 1) Execute binding assays for PAX3-FOXO1 using SMMs containing >55,000 small molecules; 2) Perform
phenotypic and biophysical characterization of putative PAX3-FOXO1 binders; 3) Synthetically optimize
chemical probes and evaluate target engagement in cells; 4) Conduct mechanistic studies of chemical probes
in cellular and murine models, in collaboration with the Validation Core. This Project will establish gross structure-
activity relationships for 1-3 compounds and use principles of medicinal chemistry to develop new analogs with
improved potency in cellular assays and physicochemical characteristics and will synthesize proteolysis targeting
chimeras (PROTACs) in an effort to explore targeted degradation of the PAX3-FOXO1 fusion protein. While the
aims of this multi-disciplinary proposal are ambitious, the Project will be enabled by the cumulative experience
of the team, as well as the extensive capabilities of our FusOnC2 Center and its Projects and Cores. Our
approach will lead to high-quality probes of PAX3-FOXO1 function that may clarify the role of the fusion as a
direct therapeutic target for ARMS. Through these efforts we also expect to define general strategies for targeting
other recalcitrant oncogenic fusion proteins with small molecules.